Scaling up Building Healthy Families in Rural Areas and Small Towns

This project addresses the lack of access to evidence-based childhood obesity interventions (EBI-CO) in rural
areas where both poverty and obesity is prevalent. Building Healthy Families (BHF) is an adapted EBI-CO
designed for, and implemented in, rural areas and has successfully achieved clinically and statistically
significant reductions in child BMI z-score (-0.27±0.22)—a similar magnitude of effect relative to previous
efficacy trials. To increase the likelihood of broad dissemination and implementation of BHF to other rural
communities we piloted the development and implementation of the BHF Online Training Resources and
Program Package (BHF Program Resources). The BHF Program Resources is a ‘turn-key’ online resource that
includes a train-the-trainer system, program materials and a data portal for use by community-based
implementation teams. In our pilot study we compared the use of the BHF Program Resources with and
without community participation in an action learning collaborative (LC) in changing RE-AIM outcomes. We
found the learning collaborative was related to improved Reach (94% vs 74% attendance), Effectiveness (BMI
z-score change -0.15±.08 vs -0.09±0.11), and Implementation (91% vs 73% adherence to protocol). Further,
Adoption and Maintenance were successfully achieved, but did not differ by condition (100% of enrolled
communities initiated the program and planned a second cohort of families). We propose to expand our pilot
into a fully powered Hybrid Type 3 effectiveness-implementation, cluster RCT to test the utility of the BHF
Program Resources Only (BHF-PO) with and without a BHF Learning Collaborative (BHF-LC). We will scale up
a bundled adoption strategy we used successfully in our pilot to engage 30 micropolitan and rural communities
across the 6-state region served by the Mountain West Family Healthy Weight Collaborative and Huntsman
Cancer Institute (NM, ID, MT, NV, WY, UT; See Letters of Support). We will randomly assign communities to
either the BHF-PO (n=15) or in combination with the BHF-LC (n=15) to determine the relative effects on RE-
AIM outcomes of reach, effectiveness (secondary outcome), implementation (primary outcome), and program
maintenance. In addition, we will assess potential mechanisms of change across RE-AIM outcomes using the
Integrated Promoting Action on Research in Health Sciences (iPARIHS) framework. Finally, economic
evaluation will be conducted to determine costs and benefits across RE-AIM outcomes.

Public health relevance
Evidence-based interventions for childhood obesity (EBI-CO) can reduce child weight status, but for families living in rural areas and small cities (<50,000 residents), the availability of inter-disciplinary healthcare teams recommended to deliver EBI-CO is low. To address this issue, we adapted an EBI-CO that includes all the materials and training resources necessary for rural program implementation and found, in a pilot study, that when paired with opportunities to learn from the program developers and other community implementation teams packaged program led to effective program delivery across 4 rural communities. In this study, we will scale up our pilot study and compare our packaged EBI-CO, with and without a learning collaborative, on outcomes such as reach, effectiveness, implementation, and potential for sustainability in rural areas.